The Empilisweni Center for Women's Health - Advancing Implementation of Equitable Cervical Cancer Control

Abstract (Overall). Cervical cancer is a leading cause of cancer-related deaths among women in low- and
middle-income countries (LMICs), and it is almost entirely preventable.1,2-4 In 2020, the World Health
Organization (WHO) announced a global strategy to accelerate the elimination of cervical by the end of this
millennium by vaccinating 90% of girls by aged 15 and screening 70% of women and treating 90% of treatment
eligible women by 2030.5 Based on strong empirical evidence of effectiveness and safety, the WHO recommends
Human Papillomavirus (HPV)-based testing followed by immediate treatment of pre-cancerous lesions, an
approach called screen-and-treat (SAT) for achieving cervical cancer control in LMICs.6 Our investigator team
at Columbia University Irving Medical Center (CUIM) and the University of Cape Town (UCT), through a nearly
thirty-year collaboration under the Khayelitsha Cervical Cancer Screening Program (KCCP), have conducted
seminal clinical trials demonstrating the safety and effectiveness of HPV-based screening and treatment.7-9
Although endorsed in global and national guidelines, the SAT approach has not yet been widely implemented.
Like most LMICs, South Africa is grappling with how to operationalize and promote the widespread and equitable
integration and uptake of HPV screening in healthcare settings. Stakeholders cite a lack of context-specific
implementation, costs, and financing as important implementation barriers. Aligned with RFA-CA-22-019 and in
partnership between the KCCP and the Western Cape Department of Health (WCDoH), we propose the
Empilisweni (isiXhosa for a place of healing) Center for Women’s Health with the overarching mission to
accelerate the integration and scale-up of evidence-based interventions for equitable cervical cancer elimination
among women in resource-constrained settings. Led by MPIs; Denny (UCT), and Kuhn (CUIMC), who founded
KCCSP, will be joined by MPI Castor (Contact: CUIMC), Mbatani (UCT), Saidu (UCT), Shelton (CUIMC),
Tehranifar (CUIMC); and Arendse (UCT/WCDoH) and collaborator Cloete (WCDoH) Informed by implementation
science frameworks and stakeholder engagement approaches, we propose to: Aim 1: Support the WHO’s global
strategy to accelerate the elimination of cervical cancer by the end of this millennium by equitably integrating
scalable, affordable HPV-based point-of-care screen-and-treat (POC-SAT) strategies to achieve the secondary
prevention cascade goal of 70% screening and 90% treatment of women who screen positive by 2030 in the
Western Cape Province of South Africa; and Aim 2. Catalyze equitable integration and sustainable scale-up of
POC-SAT by fostering effective collaboration, coordination, capacity-building, and knowledge sharing across
multiple key stakeholders. By the end of the five years, POC SAT will increase the proportion of women who are
screened and treated regionally, will complement centralized HPV testing, and be economically feasible. We will
have a strengthened capacity for leading implementation research in the region and advanced work on strategies
to inform scalable delivery and innovative financing of cervical cancer control for population-level impact.

Public health relevance
Project Narrative Although human papillomavirus-based detection followed by same-day, onsite treatment, an approach called HPV-based screen-and-treat (SAT), has been included in global and national guidelines, the approach has not yet been widely implemented outside research settings. We hypothesize that an HPV-based, point-of-care, screen-and-treat (POC-SAT) implementation strategy will increase the proportion of women who are screened and treated, will be complementary to centralized HPV testing, and will be affordable.